Implementation, Outcome and Mechanisms of Family-Based Treatment for Adolescent Anorexia Nervosa Adapted for the Home Setting: A Pilot Effectiveness Trial

PROJECT SUMMARY/ABSTRACT
Anorexia nervosa (AN) is a serious psychiatric illness that affects ~1% of adolescents and is associated with
high rates of morbidity and mortality. Family-based treatment (FBT), which involves empowering caregivers to
take control of refeeding to restore the adolescent to a normative weight and eating trajectory, is postulated to
operate via increasing caregiver self-efficacy related to refeeding, and decreasing adolescent distress through
repeated exposure to eating- and weight-related stimuli. Although FBT is currently considered the “first line”
treatment for adolescent AN, it is underutilized in community settings and is unavailable to many families for a
multitude of practical reasons (e.g., costs of treatment, limited availability of trained providers in many regions
of the country), particularly those from underrepresented sociodemographic groups. Furthermore, a substantial
subset of families do not optimally respond to FBT, which may be due to failure of newly acquired intervention
skills to generalize outside of the (typically office-based) treatment context. Home-based treatment is an
alternative to traditional office-based outpatient treatment that can reduce many pragmatic barriers to treatment
uptake and engagement, and may enhance generalizability of treatment skills as it is delivered in multiple
naturalistic settings where refeeding often occurs (e.g., home, school, community). Although home-based
models have been successfully applied to other psychiatric conditions, home-based treatments for AN have
never been tested. Moreover, FBT has undergone limited investigation in “real world” settings outside of
specialty academic and clinical environments dedicated to eating disorders. As a result, much of what is known
about FBT is based on relatively homogeneous samples with limited representation from individuals from lower
income and racial/ethnic minority backgrounds. Furthermore, it is unclear if putative FBT mechanisms apply in
the effectiveness context. The proposed R34 pilot effectiveness trial will assess outcomes, implementation,
and mechanisms of FBT for adolescent AN adapted for the home setting (FBT-HB), delivered in the context of
two community-based behavioral health agencies that serve a primarily lower-income, racially and ethnically
diverse clientele. Adolescents with AN-spectrum disorders (n=50) and their caregivers will be randomly
assigned to either FBT-HB or home-based usual care (integrated family therapy approach). Caregivers and
adolescents will provide data on weight, eating, and putative treatment mechanisms, including caregiver self-
efficacy, adolescent distress, and generalizability of treatment skills. Implementation constructs will be
measured among providers and participating families. Overall aims are to assess preliminary effects of FBT-
HB on adolescent eating and weight outcomes; FBT-HB acceptability, appropriateness, feasibility, and fidelity;
and caregiver- and adolescent-level mechanisms of change. The proposed study has clear potential to
advance scientific and clinical understanding of the real-world effectiveness of FBT for AN, including whether
adapting it for the home setting may improve its accessibility and effects on treatment outcome.

Public health relevance
PROJECT NARRATIVE Anorexia nervosa (AN) is a pernicious psychiatric illness that affects 1% of adolescents in the community and is associated with high risk for serious medical complications, psychiatric comorbidities, and suicide. Family- based treatment (FBT) is an efficacious intervention for AN in both the short- and long-term, but it is not accessible to many families, particularly those from under-represented sociodemographic groups. This pilot effectiveness trial aims to assess outcome, implementation, and mechanisms of FBT adapted for the home setting, delivered in the context of community-based mental health agencies, which will help guide research efforts towards better understanding how to tailor FBT for delivery in non-traditional treatment settings, in the context of “real world” community-based agencies, and for populations that are otherwise at risk for receiving suboptimal or no care for AN.